Pathogenic reciprocal interplay between cyst epithelium and myofibroblasts in polycystic kidney disease

PROJECT SUMMARY/ABSTRACT
Autosomal dominant polycystic kidney disease (ADPKD) is an inherited kidney disease. The goal of this study is
to determine if renal interstitial myofibroblasts play an essential role in ADPKD progression by undergoing
autophagy and supplying nutrients that support cyst growth. While myofibroblasts are known to be important for
renal fibrosis, our novel preliminary data suggests that myofibroblasts could directly regulate cyst growth in
ADPKD kidneys by paracrine mechanisms. We found that secreted factors from cyst epithelial cells such as
lactate, stimulate autophagy in myofibroblasts by a hypoxia-inducible factor (HIF1α)- dependent mechanism.
Moreover, factors such as glutamine, secreted by ADPKD renal myofibroblast- by a HIF1α and autophagy
dependent mechanism increased proliferation and cyst growth of human ADPKD cyst epithelial cells. Hence,
we hypothesize that, cyst epithelial cells use paracrine mechanisms to induce autophagy in myofibroblasts,
leading to secretion of cyst-growth promoting factors. Aim 1 will test if reducing the renal myofibroblast population
will reduce cyst growth in mouse ADPKD kidneys. Aim 2 will determine the role of myofibroblast-specific HIF1α
in cyst growth. In Aim 3, the role of myofibroblast-specific autophagy and metabolites secreted by myofibroblasts
in cyst-expansion will be examined. In addition to the innovative hypothesis, our studies will use state of the art
transgenic and tissue specific gene knockout mice and identify myofibroblast -specific secreted factors, important
for regulation of cyst growth in ADPKD kidneys. These studies are significant because we test a novel and
fundamental mechanism by which cyst epithelial cells manipulate myofibroblasts in their microenvironment to
produce nutrients to support cyst growth and disease progression in ADPKD. Although altered metabolism,
hypoxia, autophagy, and the role of the cyst microenvironment in cyst growth are emerging fields in ADPKD
pathophysiology, the importance of myofibroblast-mediated regulation of cyst growth is unclear. This study will
build on our lab's strengths in studying ADPKD pathophysiology, with co-investigators and collaborators who are
leaders in the fields of PKD, hypoxia, metabolism or autophagy. The results are expected to lead to development
of better therapies for ADPKD.

Public health relevance
PROJECT NARRATIVE ADPKD a common inherited kidney disease for which adequate treatment strategies are lacking. Our studies will examine the role of myofibroblasts in cyst growth in ADPKD, and identify novel mechanisms by which the cystic epithelium manipulates myofibroblasts into undergoing autophagy to supply nutrients and promote cyst growth.